Community Outreach and Engagement

SUMMARY/ABSTRACT - COMMUNITY OUTREACH AND ENGAGEMENT
The Office of Community Outreach and Engagement (COE) serves as the critical bidirectional interface between
all components of the University of New Mexico Comprehensive Cancer Center (UNMCCC) and a rich tapestry
of community health system partners, sovereign Tribal Nations, Hispanic/Latinx populations, cancer community
advocates, and patient support organizations. The COE facilitates efforts to overcome cancer health disparities
in our catchment area, the State of New Mexico (NM), as the focal point for engagement and communication
between the UNMCCC and our catchment area communities. Major characteristics of our catchment area
include its diverse multiethnic, multicultural, and rural population composition, primarily Hispanic, American
Indian, and non-Hispanic white; persistent socioeconomic challenges including deep poverty and food insecurity;
and access to health care challenges. Today’s COE, formalized in 2018, coordinates with and builds upon
existing UNMCCC cancer surveillance and community-engaged initiatives. Within this context, COE proposes
the following specific aims: 1) define and characterize the catchment area, 2) prioritize cancer-related needs
through engagement and communication with all stakeholders, 3) facilitate cancer research, and 4) disseminate,
implement, and evaluate multi-level cancer control strategies to reduce cancer burden within and beyond the
catchment area. To accomplish these aims, the COE has convened two major partnering groups: the Community
Advisory Board (CAB) and Tribal Advisory Council. Systematic engagement with these groups, other key
stakeholder organizations, and UNMCCC leadership led to identification of the following priority areas: 1) the
fundamental burden of cancer health disparities, 2) enhancing access to cancer care, including receipt of timely
screening and treatment, 3) reducing financial hardship associated with the continuum of cancer care, 4)
survivorship needs, and 5) examining links between environmental exposures and cancer risk/incidence. The
COE is led by Andrew Sussman, PhD, MCRP (CCPS), with COE representation on the UNMCCC Protocol
Monitoring Review Committee (Miria Kano, PhD (CCPS)), a Senior Program Manager, and four community
outreach specialists possessing unique cultural and linguistic concordance to engage American Indian, Hispanic,
and underserved communities. COE major roles and impact include integration of innovative cancer surveillance
registries and data sources to facilitate catchment area monitoring and priority area assessment; catalyzing
impactful, culturally appropriate, and rigorous cancer control and care delivery research in all priority areas both
within and beyond the catchment area; dissemination of comprehensive statewide cancer control education,
training strategies, and policy impacting recommendations; and engagement with UNMCCC clinical trial
components leading to high proportions of underrepresented minority accruals in research aligned with
catchment area priorities.